Melanoma and Melanogenesis

The importance of skin pigmentation, particularly with respect to its implications for photoprotection against skin cancers (including malignant melanoma), has resulted in a dramatic surge in research on this topic. Our laboratory continues to remain at the forefront of research on the regulation of mammalian pigmentation and focuses on characterizing: (1) pigment-related genes and their functions involved in melanocyte differentiation, (2) the biochemistry of melanins formed in the skin and their photoprotective properties, and (3) the biology of melanocyte specific differentiation antigens that serve as melanoma-specific targets.[unreadable] [unreadable] This research project is focused on characterizing parameters important to the growth, differentiation and function of normal melanocytes, and their roles in the growth and/or the metastasis of transformed melanocytes. These studies have evolved into an examination of the function and regulation of pigment-related genes, i.e. genes that encode melanocyte-specific proteins. Such proteins have generally been found to be localized in melanosomes, specific organelles that serve as the site of melanin pigment deposition; they function as catalytic and/or structural entities but perhaps more importantly, serve as specific targets of host immune responses to malignant melanoma. Our efforts in this regard have recently been targeted in the primary areas of interest noted above, all of them dealing with structure, function and/or melanoma-targeting of melanosomal proteins.